Minnesota Obesity Prevention Training (MnOPT)

Abstract
Halting and reversing upward secular trends in body weight in the US is an important medical and public health
challenge. Additional skilled researchers in obesity prevention are much needed, but training programs are
few. Obesity is a complex disorder that has multiple causes and multiple potential strategies for prevention and
treatment. The present proposal is a competitive renewal application for a training grant called the Minnesota
Obesity Prevention Training (MnOPT) program. Originally funded in 2010, its goal is to provide multidisciplinary
training for a new generation of obesity prevention scientists. MnOPT has successfully recruited 23 trainees
over the last eight years from a large pool of highly qualified applicants, 13 post docs and 10 pre-docs, all of
whom have been matched with appropriate preceptors and all of whom have been productive. We have also
conducted a successful educational program with interdisciplinary training for all fellows in biological
mechanisms and clinical and public health interventions as well as training in ethical conduct of research. We
have directed each of the fellows to educational experiences, e.g., research design and analysis, as
individually appropriate. We are proposing only minor changes to this successful program in this renewal.
Because of the size and composition of the applicant pool, we are requesting one additional postdoc training
slot to the six already approved. Robert Jeffery will remain the overall director, as well as director of the
epidemiology/behavioral track, and Catherine Kotz, professor in the Department of Integrative Biology and
Physiology, will serve as co-director and director of the basic science/clinical track. The research base at the
University of Minnesota remains strong. The number of participating faculty has decreased from 36 in the
original application to 33 in the current renewal to include only those with documented mentoring experience
and the strongest research base. The institutional support for the training program has also strengthened since
the initial proposal.

Public health relevance
Narrative Obesity is a rapidly increasingly problem in the US that increases health care costs, reduces quality of life, and reduces productivity of millions of Americans. It is one of the greatest threats to public health. Finding ways to stop increases in obesity and to reverse current trends requires intensive scientific study. Program faculty on this training grant have successfully mentored 23 promising young scientists in the last eight years, all of whom have been actively involved and productive in multidisciplinary research and 17 of whom have already matriculated. The proposed renewal will continue to provide the training necessary to fill this need.